Variation, regulation, and conservation of metabolic signaling across hibernating mammals

Abstract
Hibernation involves complex metabolic and physiological shifts that enable diverse mammalian species to
survive prolonged periods of resource scarcity. These species are able to cope with prolonged periods of fasting,
rapid weight gain and loss, periods of insulin resistance, and other physiological stresses that are associated
with metabolic disease or dysfunction in non-hibernating mammals, including humans. This project investigates
the mechanisms underlying metabolic innovation in mammals. To complete its objectives, this research project
will use comparative and functional genomic approaches to investigate the mechanisms and evolution of
hibernation across the mammalian tree, reveal detailed regulatory mechanisms underlying hibernation gene
regulation in the brown bear, which is a particularly unique and valuable hibernation model system, and directly
test the translational potential of bear serum factors for the modulation of human adipocyte metabolism. This
work will advance our understanding of the mechanisms governing hibernation in mammals and identify specific
genes, transcription factors, and signaling pathways with conserved or divergent function in hibernators
compared to humans. This research will identify specific genes and regulatory mechanisms that can be targeted
in the treatment of human metabolic diseases.

Public health relevance
Public Health Relevance Statement Hibernation enables diverse mammalian species to survive prolonged periods of resource scarcity that would otherwise be harmful to non-hibernating species, including humans. Understanding the mechanisms of hibernation, and the extent to which these mechanisms are conserved in humans, will provide valuable perspectives into human metabolic disease and dysfunction. This research will illuminate specific genes and regulatory mechanisms that will inform novel strategies to prevent and treat human metabolic diseases.